Angiopoietin-2/Tie2 signaling regulation of liver metastasis in pancreatic neuroendocrine tumors

Title: Angiopoietin-2/Tie2 signaling regulation of liver metastasis in pancreatic neuroendocrine tumors
PROJECT SUMMARY
Liver metastases are found in nearly half of PanNET patients at diagnosis while many others develop liver
metastasis after surgical resection of the primary tumor. Though the incidence of pancreatic neuroendocrine
tumors (PanNET) has increased steadily over recent decades, there are only limited therapeutic options for
metastatic PanNET patients. Furthermore, immune checkpoint inhibitors (ICI) showed the limited efficacy in
patients with metastatic PanNET due to the immunosuppressive microenvironment. Therefore, understanding
the mechanisms underlying liver metastasis, immune evasion, and their convergence on ICI therapy resistance
in PanNET is urgently necessary to improve the clinical management of advanced PanNET.
Vascular destabilization is recognized as a hallmark of tumor growth and metastasis. Angiopoietin-2
(Ang2), which binds to the receptor tyrosine kinase Tie2, is a potent vascular destabilizing factor. We
demonstrated that under inflammatory conditions, Ang2 suppresses Tie2 signaling and promotes vascular
destabilization and leakage. Importantly, emerging evidence suggests that vascular destabilization facilitates
tumor immune evasion by impairing immune cell infiltration. In preliminary studies using a spontaneous
PanNET mouse model, we found that Ang2 inhibition suppresses liver metastatic growth and improves the
survival. Ang2 inhibition also reduced vascular leakage and increased CD8+ T-cell infiltration in metastases.
We previously showed that suppression of Tie2 signaling is accompanied by ectodomain cleavage of the Tie2
coreceptor, Tie1, resulting in increased circulating levels of soluble Tie1 (sTie1). Our preliminary studies show
that elevated plasma sTie1 levels in PanNET patients have significant prognostic implications.
In this project, we will elucidate the mechanisms underlying Ang2-mediated liver metastatic progression,
immunosuppression, and anti-PD-1 therapy resistance in metastatic PanNET. In Aim 1, we will determine the
contribution of Ang2-mediated vascular destabilization to liver metastatic progression in PanNET by using
human liver metastases and function-blocking antibodies or genetic Ang2 deletion in spontaneous and
experimental PanNET mouse models. Mechanistically, in Aim 2, we will determine whether Ang2-mediated
vascular leakage impairs CD8+ T-cell infiltration in liver metastases, serving as the basis for assessing the
effects of Ang2 inhibition combined with anti-PD-1 therapy in metastatic PanNET. We will determine if Ang2
blockade sensitizes PanNET liver metastases to anti-PD-1 therapy by promoting vascular stabilization and
CD8+ T-cell infiltration in PanNET mice. Finally, Aim 3 will identify circulating levels of sTie1 at diagnosis as a
potential biomarker for tumor aggressiveness in PanNET patients. Successful completion of this project, which
elucidates the mechanisms underlying vascular regulation of the immune evasion, could significantly enhance
the clinical management of metastatic PanNET, as well as provide insights for the treatment of metastatic
disease deriving from other tumor types, especially those with poor response to ICI therapy.

Public health relevance
PROJECT NARRATIVE Nearly half of patients with pancreatic neuroendocrine tumors (PanNET) present with liver metastases at diagnosis, which correlates with poor prognosis, and the immunosuppressive microenvironment of PanNET limits the efficacy of immune checkpoint inhibitors (ICI) for metastatic PanNET patients, with a less than 10% objective response rate. Emerging evidence suggests that increased vascular leakage and poor vascular perfusion resulting from vascular destabilization impair immune cell infiltration into tumors, thus facilitating tumor immune evasion and consequent tumor progression. In this work, we propose to study role of angiopoietin-2/Tie2 signaling, which regulates vascular destabilization and dysfunction, in liver metastatic progression and in ICI therapy resistance of metastatic PanNET as well as the potential of Tie signaling molecules as sensitive cancer biomarkers for PanNET patients.